EFFECTS OF POST EXERCISE NUTRIENTS ON SKELETAL MUSCLE PROTEIN HOMEOSTASIS

Determine how increased post-exercise amino acid availability alters skeletal muscle protein accretion. Examine the potiential inteactions of increased glucose and insulin with increased amino acid availability after exercise in the modulation of skeletal muscleprotein accretion. Finally, define the importance of the timing of such increases in amino acid availability after exercise to skeletal muscle protein accretion. We are continuing recruitment of participants as our immediate focus.